Molecular Genetic Analysis Of Lymphocyte Function

Our studies of the structural basis by which several pan-anti-MHC-I mAb interact with their MHC-I (HLA-I) antigens form the basis of several engineered forms of the mAb. These are being actively studied with respect to the molecular details of their interactions and the nature of their competitive blocking effects on various NK and myeloid cell receptors. The structural and biochemical studies form the basis of planned functional studies in non-human primates, and they will be the subject of further humanization and affinity maturation studies. As information accumulates, we expect that these mAb and their derivatives may form the basis of new studies aimed at developing mAb therapies for various tumors.